The Impact of Emerging Health Insurance Designs on Diabetes Outcomes and Disparit

DESCRIPTION (provided by applicant): Patients with diabetes enjoy longer and healthier lives when their blood glucose levels are controlled and their disease is monitored carefully. Experts have long advocated for improved adherence to hypoglycemic medications and secondary prevention measures, especially for underserved populations such as ethnic minorities and the poor. However, a new type of health insurance - high-deductible health plans - may threaten patients' access to crucial medical care. Families in high-deductible health plans must pay up to $4000 per year out-of-pocket before more comprehensive coverage begins. Enrollment in these plans is growing at unprecedented rates. It is essential to understand how high-deductible health plans affect secondary prevention and outcomes among populations with diabetes and in underserved patients. Reduced levels of care could lead to accelerated disease progression and diabetes-related deaths. This proposal seeks to assess the impact of high-deductible health plans on diabetes secondary prevention and outcomes in a nationally representative diabetic population. Measures of secondary prevention will include hemoglobin A1C testing, lipid testing, and retina exams. Outcomes will include high severity emergency department visits, preventable hospitalizations, and hospitalization days. The study will also quantify the degree to which transition to a high-deductible health plan affects socioeconomic and racial/ethnic disparities in diabetes secondary prevention and outcomes. Finally, the study will determine impact of high-deductible health plans with and without full drug cost-sharing on medication adherence and outcomes. This study will draw from a 12-year rolling sample of members from a large national health insurer whose employers mandated a switch from traditional to high-deductible health plans. Employer- and member-level propensity score matching will be used to create a concurrent control group with minimal selection effects. The study will employ a strong quasi-experimental pre-post with comparison group design to examine our outcomes of interest. This will be the first study to examine these research questions on a national scale and the first to use an innovative member-level method for detecting at-risk populations. Results should help inform policy makers, patients, and physicians regarding optimal health plan benefit designs for patients with diabetes.

Public health relevance
PROJECT NARRATIVE Health insurance plans that require patients to pay high out-of-pocket expenses are rapidly replacing low cost- sharing plans. This project seeks to improve public health by determining the effects of such health plans and their novel design features on patients with diabetes. These studies will allow the designers of health plans to optimize care and outcomes for patients with diabetes. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS / RESEARCH OBJECTIVES Diabetes is a growing threat to public health. The incidence of type 2 diabetes has doubled in the last 30 years and rates are likely to accelerate given the rapid rise in childhood obesity. Lifetime diabetes risk among ten year-old children today is estimated to be 33 to 39 percent, and patient life spans could be reduced by 12 to 19 years. In 2005, over 230,000 patients died of diabetes complications(1). Disease burden is unequally concentrated in vulnerable populations. Studies have found racial and socioeconomic disparities in diabetes rates and quality of care, even among commercially insured individuals(2, 3). In the last two decades, efforts to reduce the incidence and severity of diabetes have focused on pharmacological and lifestyle interventions, implemented through clinicians, disease management programs, and public health awareness. Recent efforts have targeted obesity prevention given its correlation with type 2 diabetes. Nevertheless, rates continue to climb. Because type 2 diabetes is associate with modifiable lifestyle factors, some commentators have suggested that health systems should encourage greater individual responsibility for health. Consumer-directed health care advocates have been vocal proponents of this approach(4-6). They suggest that providing patients information about the quality of medical services while exposing them to full costs will create "activated health care consumers."(6) This theoretical framework began to be implemented in the form of "consumer-directed health plans" in the early years of this decade (7-9). Managed care organizations began developing health insurance products that included high annual deductibles, internet- based quality information, and mechanisms for saving money toward health expenses(10). Annual deductibles in typical plans range from $3400 to $3700 for family plans(11) and savings may be in the form of Health Reimbursement Accounts or Health Savings Accounts. Advocates theorize that not only will members seek low cost and high quality care, they will also adopt healthy behaviors to reduce future costs. For example, patients with diabetes might improve their diets, exercise regimens, and adherence to drugs and routine monitoring. The expansion of high-deductible health plans (HDHP) represents a natural experiment of tremendous proportion. Forty percent of employees at small businesses now face annual deductibles of at least $1000 and the percentage of employers offering HDHPs increased by 200% between 2005 and 2009(12, 13). Furthermore, the new national health care legislation is expected to stimulate an "explosion" in HDHP growth(14) because of mandates for low-cost commercial health plans(14, 15). The rapid growth in HDHPs has been accompanied by concern - based on studies such as the RAND Health Insurance Experiment(16) - that high cost sharing may reduce appropriate utilization. Recent evidence has emerged that when necessary care such as essential medications(17-19) and screening tests(20) are subject to deductibles, utilization decreases. A more recent school of thought has promoted "value-based insurance"(4-6, 16, 21, 22) as a remedy. Such plans seek to broadly control costs using high deductibles while preserving evidence-based care through financial incentives. For example, plans might selectively exempt preventive visits or hypoglycemic drugs from full cost-sharing. A large majority of HDHPs now have some value-based design features(12). Despite their rapid expansion, the fundamental hypotheses of consumer-directed health plans and value- based insurance have largely gone untested. Among diabetic populations, a few small studies have suggested that excluding secondary preventive services from cost sharing preserves utilization (23, 24). However, these studies have not controlled for member-level selection or examined adverse clinical outcomes, especially among the vulnerable patients most likely to be affected by high cost sharing. Furthermore, no studies have compared the impact of HDHPs with and without full drug cost-sharing on diabetes quality of care. Using a longitudinal, national data set of 1.9 million members who did not select into their health plans, and including member-level socioeconomic status (SES) and outcomes data for 310,000 diabetes patients, we propose the following three Specific Aims: Aim 1: To determine the impact of HDHPs on disease monitoring and clinical outcomes in a national diabetic population. Measures of disease monitoring will include hemoglobin A1c, lipid, and urine microalbumin testing; availability of blood glucose test strips; and retina examinations. Clinical outcomes will include high severity emergency department (ED) visits, preventable hospitalizations, and hospitalization days. Ancillary Study 1 will seek to validate the Billings/Ballard algorithm for ED visit classification among diabetic patients. Aim 2: To determine the differential impact of HDHPs on the outcomes from Aim 1 among black, Hispanic, low SES, and high morbidity diabetic populations. Ancillary Study 2 will compare ecological and individual-level socioeconomic predictors of utilization in a diabetic population. Aim 3: To determine the impact of HDHPs with and without full drug cost-sharing on medication adherence, high severity ED visits, preventable hospitalizations, and hospitalization days. Ancillary Study 3 will assess the impact of increased medication cost-sharing on patients' total out-of-pocket (OOP) health care spending.